Optical Phantoms Mimicking Microvascular Cerebral Blood Flow (Supplement)

PROJECT SUMMARY
The primary goal of this administrative supplement project is to characterize, optimize and disseminate the
optical phantoms mimicking microvascular cerebral blood flow (CBF). In our parent R15 study (EB034986)
entitled “Affordable Shortwave Infrared Spectroscopy for Stroke Risk Screening in Children with Sickle Cell
Disease“, we have proposed to construct the advanced multilayered microfluidic phantoms to verify our
prototyped optical flowmeter. Traditionally, the most common optical flow phantom is simply a bulk liquid wherein
blood flow is manipulated by adjusting temperature, viscosity or particle size. The proposed phantoms here
address the limitations of conventional laboratory-based optical phantoms by mimicking the multiple features of
brain flow models: 1) two-layer features: extracerebral and cerebral layer with varying thickness of the
extracerebral layer, 2) optical (scattering and absorption coefficients) properties and physiologically relevant flow
rate of each layer 3) micro-sized multi-channel flow mimicking the dimension of arterioles, capillaries and venules.
For this purpose, the overall objective of this administrative supplement is to characterize and optimize the
multilayered microfluidic phantoms built using both non-cleanroom and cleanroom methods. We envision the
proposed phantoms will be employed for 1) evaluation the basic performance of the developed optical flowmeter,
2) daily-basis quality check before any clinical measurements 3) benchmark reference for comparison of the
different technologies. Successful completion of this proposed project will pave the way towards the first-ever
standardized multilayered micro-sized flow phantoms to improve repeatability, reproducibility and quantification
of the diffuse optics technologies that have the potential for clinical translation as a bedside tool for CBF
monitoring.

Public health relevance
PROJECT NARRATIVE The diffuse optics technique holds promise as a bedside cerebral blood flow monitoring tool for screen, diagnosis and therapeutic management of many brain-related diseases. In this supplement, we will characterize and optimize the optical phantoms mimicking multilayered microvascular cerebral blood flow. We envision the phantoms will serve as a standard reference for daily calibration, performance evaluation and quality control, contributing to clinical translation of light-based microvascular flowmeter through wide dissemination.